Computational and mathematical modeling of biomedical systems

This program prepares scientists for research careers in the computational and mathematical
modeling of medically significant biological systems through interdisciplinary training at the
predoctoral level. Noted for its well-established system of interdisciplinary graduate programs
and for its tradition of collaborations across departmental boundaries, the University of Arizona
provides a highly suitable environment for such training. Fifteen training faculty with
appointments in multiple departments and interdisciplinary graduate programs provide strength
in five broad areas: bioinformatics; molecular dynamics; cellular processes; physiology and
pathophysiology; biostatistics and stochastic processes. Students will be drawn from multiple
graduate programs in mathematical and life sciences, including the programs in Applied
Mathematics and in Biochemistry and Molecular & Cellular Biology. In most cases, students will
receive two years of support from this program, starting in their second or third year of graduate
training. Trainees will pursue the coursework requirements of their own graduate programs and,
in addition, take graduate courses in mathematical modeling and in bioinformatics, which are
tailored to the trainees' needs and take into account their diverse scientific backgrounds. All
trainees will take part in a weekly Quantitative Biology Colloquium that has been running
continuously for more than twenty years. This colloquium includes presentations by students,
faculty and visiting speakers, and promotes dialog between trainees and faculty with primarily
mathematical or computational backgrounds and those with strong biological training. It will
include components explicitly devoted to training in responsible conduct of research, methods
for enhancing reproducibility, and career development including preparation for a range of
careers in biomedical research. Trainees will carry out their doctoral research with advisors
whose research, whether theoretical or experimental, emphasizes application of theoretical
approaches to biomedical problems. Trainees participating in this program will not only receive
research training in relevant areas, but, equally importantly, will develop the ability to
communicate and collaborate across traditional disciplinary boundaries and to work with
researchers with complementary expertise. Researchers with such skills are critically needed in
many areas of biomedical science in which sophisticated theoretical approaches are necessary
in order to achieve further progress.

Public health relevance
In many areas of biomedical science, quantitative theoretical approaches are necessary in order to understand complex biological systems. This program prepares scientists for research careers in the computational and mathematical modeling of medically significant biological systems through interdisciplinary training at the predoctoral level. Trainees receive training in relevant research areas and develop the ability to collaborate across traditional disciplinary boundaries with researchers with complementary expertise.